HIGH DOSE ACYCLOVIR VERSUS VIDARABINE IN NEONATAL HERPES SIMPLEX INFECTION

We hypothesized that treatment with high dose acyclovir would decrease mortality and morbidity of CNS or disseminated neonatal herpes simplex virus infection both acutely and long-term. This trial is a randomized, double-blind controlled clinical trial utilizing high dose acyclovir Vs. standard vidarabine therapy. Patients will be treated in the GCRC for twenty-one consecutive days and then intermittently from day 28 through 6 months. Laboratory work including spinal tap for CSF fluid will be done on days 1 and 21. CT will be done on days 1 and 21 with other CTs as medically indicated. Follow-up out-patient visits will be at 1, 2, 3 and 4 years and will include neurological and developmental assessments. During the first phase of the study, 16 babies nation-wide were enrolled at a dosage of 45mg/kg/day. There was no evidence of toxicity at this doseage; thus, medication doseage was escalated to 60mg/kg/day. A total of 72 patients have been enrolled at the 60mg/kg/day dose at all centers. No new patients have been enrolled at UAB this year; 3 outptaient visits were recorded for follow-up.